ROLE OF GH DEFICIENCY IN SHORT STATURE OF CONGENITAL ADRENAL HYPERPLASIA

The aims are to test the hypothesis that standard glucocorticoid replacement therapy of congenital adrenal hyperplasia (CAH) causes growth hormone (GH) insufficiency, and to test the hypothesis that this GH-insufficiency is due to inhibition of GH secretion indirectly by increasing somatostatin tone. The protocol consists of growth hormone provocative testing in prepubertal children with CAH. Standard arginine, levo-dopa, and GH releasing hormone testing are to be carried out. Patients who are found to be GH-insufficient will be treated with recombinant human growth hormone (Protropin).